Synovial Macrophage Transcriptional Signatures for Predicting Therapeutic Efficacy

Despite the many therapies for patients with rheumatoid arthritis (RA), there is little information to
guide selection of the most effective treatment for an individual patient. Forty-sixty percent of
patients with RA respond (defined by ACR50 response criteria) to conventional disease modifying
anti-rheumatic drugs (cDMARDs) or cDMARDs plus anti-tumor necrosis factor (TNF) therapy.
Moreover, 20-40% of RA subjects in clinical trials never demonstrate even a minimal response
(ACR20 response criteria). Hence, there is a clear need to develop precision-based therapy for
patients with RA, whereby novel biomarkers will enhance our ability to predict therapeutic
response and limit ineffective therapy. For the most part, peripheral blood has been utilized for
identifying predictive biomarkers, but these studies lacked sufficient precision to allow their
incorporation into clinical practice. Thus, similar to an oncologist, who identify mutations through
sequencing of tumor biopsies to direct therapy, our approach is to biopsy the synovium, the target
organ in RA to identify changes that reflect sensitivity or resistance to a particular therapy.
We brought together six leading medical centers to create REASON, a consortium with
an established framework for patient recruitment, curation of clinical data, ultrasound-guided
synovial biopsies, cell sorting, RNA sequencing (RNA-seq), and computational analyses. Our
data show that macrophages isolated from ultrasound-guided synovial tissue biopsies obtained
from patients with RA are sufficient for RNA-seq, exhibit transcriptional differences across patients
with RA, and, importantly, set the framework for the stratification of patients with RA according to
the most prominent disease pathway. We are the first to identify 6 transcriptional modules of
co-regulated genes from isolated synovial macrophages via ultrasound-guided synovial
biopsy, that are individually associated with clinical disease status and cDMARD or
biologic therapy (bDMARD). This study established REASON as a leader in the United States
for ultrasound-guided synovial biopsies and demonstrates the feasibility and therapeutic potential
of isolating low numbers of synovial macrophages for RNA-seq to establish a precision-medicine
approach for RA therapy and to understand pathobiology. While our published study identified
transcriptional signatures associated with bDMARD or methotrexate usage in RA patients with
active disease, there is a central need to identify genes that are predictive of response to therapy.
Our overarching hypothesis is that functional genomic analysis of synovial macrophages will
identify novel transcriptional signatures that inform on response to particular therapies in
individual patients, thereby enabling researchers and, ultimately, clinicians to identify the drug
most likely to work for each patient.

Public health relevance
Currently, rheumatologists prescribe therapy to patients through a costly and time-consuming trial-and-error process, which is currently the standard of care. This is clearly evident for patients with RA, where there are numbers of biologic therapies for patients but no clinical reason for administering one biologic therapy above another. The utility of a biomarker to identify how a patient will respond to a particular therapy cannot be overstated.